Admin Core

Project Summary/Abstract
Administrative Core
The Administrative Core (AC) will provide the leadership and administrative support for the Center, addressing
the theme of "Engaging multiethnic populations in research and eliminating disparities in cardiometabolic
conditions in communities across Los Angeles and Orange Counties," which incorporates the RFA-MD-21-007
priority areas of scientific focus: eliminating disparities for the commonly co-occurring risk factors and
complications of the cardiometabolic diseases that disproportionately affect the multiethnic populations
represented in Southern California, prioritizing equitable prevention and care for hypertension, stroke,
diabetes, and chronic kidney disease. The AC will provide the intellectual leadership across all activities and
ensure that the Center's scientific focus is maintained and harmonized between partner institutions by
providing operational management and close financial oversight. Along with the Investigator Development
Core (IDC) and the Community Engagement Core (CEC), the AC will provide linkages to the other NIH funded
centers and studies, as well as the NIH Coordinating Center and other institutional partners. The AC will create
procedures and infrastructure for standardization of Data Collection, Equipment, Procedures, and Training
Protocols. Working closely with the IDC, the AC will oversee the annual selection of pilot grants addressing the
Center's theme and submit the recommended pilot studies to the NIMHD Project Officer for approval. The
administrative staff will support all pilot research facilitation, including structured check-ins, administration
support, linkage to other existing NIH- funded Centers or funded projects, and connection to appropriate
mentors for the content area of interest. The AC and IDC will ensure the recruitment and retention of
promising investigators, particularly those from underrepresented backgrounds, and the viability of mentoring
and training relationships among affiliated institutions. Through structured evaluation plans, the AC will
develop, maintain, and monitor milestones towards the stated aims and track successful completion of Center
Projects, Pilot Awards (with the IDC), and Community Catalyst Awards (with the CEC).